Institutional Career Development Core

This proposed KL2 supplement award will provide Dr. Blake Langley, ND, MS, LAc with the necessary
protected time, resources, didactic training, and mentored guidance from an interdisciplinary team to develop
into an independent researcher. The planned completion of a master's degree in Epidemiology is a critical
component to achieving independence as a researcher. The intensive mentorship, pragmatic experience, and
clinical-didactic training over three years will provide fundamental training to a clinician-scholar in the design,
collection, analysis, and interpretation of both mechanistic biomarker data and patient-reported outcomes. The
proposed research project will generate preliminary data for future grant applications addressing the prevention
and treatment of a serious illness: anorexia, the abnormal loss of appetite for food. Anorexia contributes to
malnourishment and is a predecessor to cachexia (weight loss >5% of total body weight) in cancer, chronic
obstructive pulmonary disease, chronic kidney disease, and congestive heart failure. Cachexia is implicated in
up to 20% of cancer-related deaths, poses a risk to an estimated 60-70% of patients with pancreatic and
gastric cancer, and is associated with negative impacts on quality of life, treatment adherence, and overall
survival. A growing body of research supports acupuncture as an efficacious intervention for anorexia, while
auricular acupressure, an acupuncture technique without infection risk that uses seeds from the Vaccaria
segetalis plant, may target multiple mechanisms of actions that address cachexia risk factors. Auricular
acupressure interventions must consider the feasibility and acceptability to specific populations, including
patients and providers. The broad objective of the scholar's research project is to train an early career
investigator on the design, conduct, and analysis of a pilot and feasibility trial of an auricular acupressure
intervention delivered in a multidisciplinary outpatient setting. The proposed study is an 8-week randomized,
controlled pilot and feasibility trial of auricular acupressure plus standard care (active arm) vs standard care
only (control arm). Auricular acupressure ear seeds will be applied weekly and maintained for five days after
each application for 8 weeks. Participants will gently stimulate each seed bilaterally for three minutes, three
times per day. The primary aim of the trial is to assess the feasibility and acceptability of an auricular
acupressure intervention to improve appetite prevent weight loss in 66 adults with pancreatic and
gastroesophageal cancer with low appetite. The secondary aim is to estimate the effect size and variance in
weight loss and change in appetite for future studies on the efficacy of auricular acupressure in cancer patients
with low appetite. The exploratory aim will examine potential inflammatory mechanisms by which auricular
acupressure impacts weight loss and appetite, and the intervention's impact on quality of life. The results of
this trial will inform future studies on the efficacy of such an intervention and should be applicable to future
research on anorexia and cachexia in both cancer and non-cancer populations.

Public health relevance
Anorexia (abnormal loss of appetite for food) and cachexia (weight loss >5% of total body weight) pose significant risks to quality of life and survival of patients with cancer and other chronic conditions; few existing interventions are both effective and have high provider utilization. This career development award will train an emerging early career clinician-scholar in the development, conduct, and analysis of a novel pilot and feasibility trial assessing the feasibility and acceptability of an auricular acupressure intervention—an acupuncture technique without needles—to decrease weight loss in patients with cancer who are at risk for significant weight loss. Results of this trial will inform future studies seeking to use auricular acupressure to prevent anorexia and cachexia in patients with cancer and other chronic conditions.